Roles of the LTR5_Hs human-specific endogenous retroviruses in primordial germ cells

Human endogenous retroviruses (HERVs) are remnants of retroviruses occupying 8% of human genome.
Transcription of HERVs is generally suppressed by epigenetic mechanisms; but recent studies, including ours,
have provided evidence that LTR5_Hs, the human-specific HERV species, is specifically reactivated in human
Primordial Germ Cells as well as its human pluripotent stem cell (hPSC)-derived cell culture model hPGCLCs
(human Primordial Germ Cell-Like Cells). Currently available evidence obtained from our preliminary studies
as well as presented in very recent literature supports that LTR5_Hs is required for conversion of hPSCs to
hPGCLCs and that hPGCLCs (but not hPSCs) release Virus-Like Particles (VLPs) from plasma membrane.
Taking advantage of our recent success in Long-Term Culture hPGCLCs (LTC-hPGCLCs), this project will
examine (1) whether the reactivation of LTR5_Hs creates new, hPGCLC-specific boundaries of the
topologically associated domains (TADs), which may support germline differentiation of hPSCs; and (2)
whether VLPs released from hPGCLCs can convey viral and/or non-viral molecules, including the retroviral
reverse transcriptase, from LTC-hPGCLCs to other human cells. Our Specific Aim 1 will use the CARGO
(chimeric array of gRNA oligos)-CRISPRi and the piggyBac vector for comprehensive suppression of the 697
known copies of LTR5_Hs and random insertion of exogenous copies of LTR5_Hs from/to the genome of
hPSCs and LTC-hPGCLCs. The engineered cells will be subjected to deep sequencing analyses of TADs (Hi-
C seq), transcriptomes (RNA-seq), and epigenomes (ChIP-seq). Efficiencies of (A) in vitro conversion of
hPSCs to hPGCLCs or cells representing the three germ layers, and (B) male LTC-hPGCLC differentiation to
gonocytes in the xrTestis xenogeneic reconstituted testis organoid culture system, will be evaluated by single
cell RNA-seq as well as immunofluorescence staining. Specific Aim 2 will attempt to establish the LTR5_Hs
origin of VLPs released from LTC-hPGCLCs by immunogold staining and enrich the VLPs for further analyses
of their components such as RNA species, proteins, and enzymatic activities derived from viral or host cells.
Attempts will be further made to label the VLPs with peptide antigen tags and/or fluorescence proteins to
determine whether the VLPs can fuse into, and possibly internalized in, other human cells surrounding
hPGCLCs in human embryoids generated in a microfluidics system as well as other types of hiPSC-derived
embryonic cells. If the proposed experiments are successfully completed, we expect to obtain important
mechanistic insights into how retrovirus-derived, human-specific genomic elements contribute to development
of germline cells, potentially creating a novel paradigm that highlights the physiological importance of exapted
HERVs in human reproduction. Our experiments may also support the novel concept that VLPs function as an
intercellular conveyer of viral and/or host cell molecules, potentially revolutionize our knowledge about
physiological roles of HERVs in human development and health.

Public health relevance
Project Narrative Human endogenous retroviruses (HERVs) are remnants of retroviruses that were integrated into human genome millions of years ago. Although HERVs are generally suppressed in the current human cells, we found that LTR5_Hs, a special HERV species that is found only in the genome of humans but not monkeys, is uniquely activated in early-stage gamete precursor cells, which release retrovirus-like particles from their surface. This project will attempt to determine possible roles of LTR5_Hs in development of the human gamete precursor cells, testing a hypothesis that production of sperm and eggs in the normal human body is dependent on reactivation of this otherwise suppressed viral DNA.